BREAST CANCER PREVENTION PROJECT

The proposed project is to implement dietary changes to fight breast cancer. We will work with 40 women at high risk for the disease and study the effects of low-fat and high-fiber diet on breast fluid secretion and cytology.